Specialized RNA analysis center for integrative genomic analyses

ABSTRACT
Projects like The Cancer Genome Atlas (TCGA) have generated a tremendous amount of data characterizing
the genomic events in cancer and highlighting the deep complexity and significant heterogeneity that can make
precision medicine challenging. Molecular subtyping has helped to identify groups of samples with shared
genomic characteristics that can be used for clinical decisions. RNA expression has played a strong role in
molecular subtyping over the last twenty years. Integration of RNA expression data with other data types that
are being generated as part of the Genome Data Analysis Network have improved our knowledge of
tumorigenesis and separating driving events from passenger events. Our team has over a 20 year history of
innovation in expression technologies, innovating across generations of assays and projects. We propose to
apply our knowledge, experience, and methods to address the projects that will be addressed in this
cooperative agreement including clinical trial samples from ALCHEMIST or the Clinical Trials Sequencing
Program. We propose to address four specific areas of research including `expression/mRNA analysis',
`Spatial genomics data analysis', `data integration', and “clinical outcomes.” We will provide 1) analysis of RNA
sequencing and expression data, 2) normalization and analysis methods of spatial transcriptomics data, 3)
integrative genomic approaches for cancer classification and characterization, and 4) analysis of biomarkers
for association with clinical and other molecular features. We will provide our data to other GDACs and work
collaboratively with them to integrate our analyses and generate data for sharing with the larger scientific
community through the Genome Data Commons.

Public health relevance
Project Narrative Large scale, multi-platform genomic projects in translational studies are often difficult to accomplish by individual laboratories. Collaborate team science networks, like The Cancer Genome Atlas and the Genome Data Analysis Network, bring together researchers with varied expertise to generate, analyze, and provide the data back to the research community for larger use and impact. We propose to provide expertise in RNA sequencing, spatial genomics, data integration, and clinical outcomes analysis as a Genome Data Analysis Center in support of the Genome Data Analysis Network.